Mapping amyloid, tau, and neurodegeneration markers with neuropsychiatric phenotypes and genotypes in Alzheimer's disease continuum using machine learning

Project Abstract / Summary
Alzheimer’s disease (AD) is the leading cause of dementia and has significant medical and public health
concerns. Despite extensive efforts, the exact relationships between in-vivo amyloid-beta (A), tau (T), and
neurodegeneration (N), neuropsychiatric symptoms (NPS), vascular risk factors, and genetic risks for NPS in
AD are poorly understood. Patients with AD pathology exhibit neurobiological and NPS heterogeneity
characteristics. The central goals have been to better understand AD’s underlying neurobiological heterogeneity
mechanisms and improve outcomes. This study plans to leverage in-vivo ATN markers from amyloid PET, tau
PET, and MRI to investigate the multivariate relationships between these markers and neuropsychiatric
phenotypes and genotypes. This project will utilize large-sample data from the Alzheimer’s Disease
Neuroimaging Initiative (ADNI), Washington University’s Knight Alzheimer’s Disease Research Center (Knight
ADRC), Baltimore Longitudinal Study of Aging (BLSA), and National Alzheimer’s Coordinating Center (NACC)
cohorts. This study will be the first to systematically investigate the multivariate relationships between ATN
biomarkers, NPS, vascular risks, and genetic risks for NPS via machine learning predictive modeling and
heterogeneity analytics in AD. In all cohorts, the project will consistently and optimally quantify PET as regional
distribution volume ratio (DVR) and standard uptake value ratio (SUVR), as well as MRI as regional volume
measures. We will integrate these cohorts and generate harmonized data resources for machine learning
method developments and their applications. Aim 1 will develop and optimize machine learning/artificial
intelligence methods in the context of regional ATN biomarkers and identify their multivariate predictive
relationships with global NPS and highly prevalent domain-specific NPS features. This aim will identify dominant
ATN regional hubs collectively involved in NPS processes. Aim 2 will identify the regional heterogeneity of ATN
biomarkers via semi-supervised machine learning and reproducibility analytical methods. This aim will correlate
the ATN profiles and NPS prevalence and severity between identified subgroups of patients or controls and each
subgroup of patients to test the hypothesis of whether ATN and NPS phenotypes differ between subgroups of
patients. Aim 3 will examine the relationships of individualized ATN heterogeneity signatures with baseline NPS
and longitudinal trajectories in NPS. Aim 4 will study vascular risk and genetics for NPS to test whether ATN and
NPS heterogeneity signatures have differential genetic etiologies. In summary, this innovative project will provide
critical information on neuropsychiatric aspects of AD mechanisms and significantly contribute to precision
medicine in the diagnosis and treatment of AD patients with NPS.

Public health relevance
Project Narrative / Public Health Relevance This project investigates the relationships of brain amyloid PET, tau PET, and MRI markers with neuropsychiatric symptoms (NPS), vascular risk factors, and genetic risks for NPS in mild cognitive impairment/Alzheimer’s disease patients and cognitively normal controls using machine learning/artificial intelligence approaches. This project will provide the first evidence on whether there are potential subgroups of patients relative to controls, as well as whether they exhibit distinct relationships in terms of PET and MR imaging markers, NPS, vascular risk factors, and genetic risks. This project will significantly advance our understanding of disease mechanisms, with a novel emphasis on neuropsychiatric aspects, and aid in advancing precision medicine approaches for diagnosing and treating Alzheimer’s disease with NPS.